Evolution of Psychosis in Youth: Multimodal Risk and Resilience Markers

PROJECT SUMMARY
Efforts at early identification of individuals at risk for psychosis are propelled by the realization that psychosis is
neurodevelopmental, with brain and behavioral abnormalities anteceding diagnosis of schizophrenia (SZ) by
years. As longer duration of untreated psychosis portends poor outcome, early identification is important to
bend the developmental trajectory in a favorable direction. Since most current studies of psychosis risk are
based on help-seeking samples, there is a gap in knowledge on how psychosis unfolds in diverse community
samples. While it is generally recognized that genomic and environmental factors (GxE) contribute to risk for
psychosis, there is a paucity of complementary integrative studies that can chart causal pathways. Genomic
“case-control” GWAS studies of SZ identified multiple common alleles permitting calculation of a polygenic risk
score (PRS). Recently, increased attention has been given to childhood adversity related to SZ. The goal of
the proposed R01 is to build on our genotyped ~10,000 Philadelphia Neurodevelopmental Cohort (PNC) of 8 to
21 years old youths studied in 2009-2011, where we are following those who meet criteria or are at risk for
psychosis (PS) and typically developing (TD) participants, whose current age range is 15-30 years. Available
multi-level “deep phenotyping” includes clinical, neurocognition and multi-modal neuroimaging on a subsample
of ~1600. We have developed a preliminary environmental risk score (ERS) and will use it to dissect GxE. The
proposed followup design will recruit PS and TD participants with the highest and lowest scorers (quartile) on
the ERS, and within each of these four cells we will examine 120 individuals, 60 males and 60 females (total
N=480). This sample will be examined clinically, neurocognitively and with multimodal neuroimaging. We will
test the hypothesis that genomic vulnerabilities, based on PRS and family history, and environmental adversity,
based on ERS, updated longitudinally, affect onset and course of PS by altering brain development in
temporolimbic regions affecting fronto-limbic connectivity that underlies social functioning. We will augment
current data with information on risk and resilience and multimodal brain-behavior parameters to establish
developmental trajectories during this critical period of brain maturation when psychosis emerges. Our aims
are: 1. Examine effects of ERS on PS clinical features and progression in relation to PRS. 2. Investigate brain-
behavior parameters that bridge from genetic and environmental factors to clinical manifestations. 3. Establish
developmental trajectories for PS features, associated brain parameters and neurocognitive deficits, and apply
novel computational models to enable an adaptive “risk and resilience calculator”. The proposed study will
produce the data absent for a diverse US community sample but needed to move psychiatry into the precision
medicine era. The project will inform on genomic and environmental risk and resilience indicators, offering an
essential rung in the ladder toward individualized prediction, a part of implementation science. As with the
PNC, data and associated algorithms will be a resource shared with the scientific community.

Public health relevance
PROJECT NARRATIVE The proposed R01 aims to bridge genomic, environment and phenotypic brain-behavior measures to advance the understanding of risk and resilience to psychosis. We will build on informative samples of the Philadelphia Neurodevelopmental Cohort and integrate multidimensional behavioral measures of psychosis and cognition, multimodal neuroimaging parameters of brain structure, function and connectivity, environmental parameters, and genomic variations in risk for schizophrenia. Computational modeling will aim at developing risk and resilience predictors, essential for early identification and intervention during a dynamic period of brain maturation.